How SSB Regulates YoaA-chi's Function in DNA Damage Repair

Project Summary/Abstract
DNA is frequently damaged by exogenous sources ranging from exposure to UV light to toxic chemicals in the
environment. To fix the damage caused by these agents and maintain genomic stability, cells have multiple
efficient DNA repair mechanisms. Some damage, though, will inevitably escape repair if the burden of damage
is too high. Unrepaired DNA damage can block DNA synthesis and have serious consequences for the cell
and for human health. A study by Brown et al. used azidothymidine (AZT) as a tool to block replication in E.
coli to discover essential genes for resolving stalled replication forks. AZT is a thymidine analog that can be
incorporated during synthesis and prevents primer extension, causing replication to stall and single-strand
DNA gaps to form. Two genes, yoaA and holC, were discovered to be vital for resolving stalled DNA replication
in AZT treated E. coli cells. The yoaA gene encodes for an XPD/Rad3-like helicase. The four human XPD/Rad-
3 like helicases (FANCJ, XPD, RTEL1, and CHLR1) contribute to genomic stability and if compromised, can
cause various genetic diseases and an increased risk of cancer. The holC gene encodes for chi, which is a
part of two different complexes. Chi is an accessory subunit of the DNA polymerase III clamp loader and forms
a complex with the holoenzyme. Chi also binds YoaA to create a functional YoaA-chi helicase. Chi is known to
bind single-stranded DNA binding protein (SSB) and this interaction is necessary for resolving lesions that stall
replication. SSB is an essential protein found in all domains of life, coats single-stranded (ss) DNA, and
interacts with over a dozen DNA repair and replication proteins. How YoaA, chi, and SSB work together to
resolve damage that halts replication is unknown. Therefore, this fellowship aims to characterize SSB
interactions with YoaA-chi with biochemical techniques to understand this novel repair pathway. It is
hypothesized SSB regulates the ability of YoaA-chi to unwind double-stranded DNA to resolve lesions at the
replication fork based on preliminary data which shows that the helicase activity of YoaA-chi is decreased in
the presence of SSB. How SSB binds YoaA-chi will be elucidated, be it either by the known location on chi or
by a new interaction possibly on YoaA (aim 1). Because SSB regulates a variety of DNA-binding proteins
through various mechanisms, several facets of YoaA-chi that SSB could regulate will be investigated. It will be
determined if SSB changes the substrate affinity of YoaA-chi (aim 2) or the helicase activity of YoaA-chi (aim
3). This will be the first study into how SSB regulates YoaA-chi and the contribution these proteins have in a
novel DNA repair mechanism. This research will also provide significant contributions in my training to become
an independent biochemist and the environment at the University of Florida will allow me to be successful.

Public health relevance
Project Narrative Human XPD/Rad3-like helicases are critical enzymes for DNA repair and maintaining genomic stability. This project will use Escherichia coli as a model system to study the interaction between an E. coli XPD/Rad3-like helicase and single-stranded DNA binding protein to add to our knowledge of XPD/Rad3-like helicases. This foundational research will not only open doors to creating therapies for patients suffering from XPD/Rad3-like helicase genetic based diseases, but will also give insight into a novel DNA repair pathway that will have far reaching implications for the multitude of ailments caused by stalled DNA replication.